Identification of genomic regulatory elements in pancreas cells

Using cutting-edge genomic technologies, we have mapped and categorized thousands of genomic elements that might be putative regulators of pancreas cell lineages. We identified chromatin regions that are associated with cell type-specific gene expression. Our work has revealed an enhancer logic that suggests a mechanism for the diversification of pancreas cell lineages during development. Our results also revealed previously unrecognized links between endocrine and exocrine pancreas in diabetes risk.